BIOSTATISTICS/BIOINFORMATICS CORE

This Core brings together biostatisticians and bioinformaticians who are experienced in the scientific areas covered by the SPORE and who are already close collaborators with SPORE lead investigators.

Public health relevance
Core researchers have a track record of methodological contributions, considerable experience in the design and analysis of both laboratory and clinical data, and expertise in biomarker discovery, evaluation, validation and disease prediction modeling to facilitate translation of the biomarker-based projects. Core members will provide integrated support for the design and analysis of SPORE major projects and pilot projects.